Fast Numerical Modeling Of Medical Ultrasound For Therapy And Imaging

Abstract:
Many important developments in medical ultrasound are enabled by large-scale ultrasound simulations, which are
essential for the design, evaluation, and optimization of new devices and applications. Despite the pervasiveness
of computer simulations in medical ultrasound, numerous problems in diagnostic and therapeutic ultrasound
remain unsolved, where better numerical models are expected to play a crucial role in the solution to these
problems. In particular, signiﬁcant improvements are needed in the available software for simulations of shock
waves produced by histotripsy transducers to facilitate effective noninvasive treatments of liver, prostate, and brain
tumors. Better, more effective simulation software is required to enable improvements in shear wave imaging
of liver ﬁbrosis, thyroid tumors, and breast tumors, and enhanced software tools are needed for simulations
of ultrafast imaging and of other dynamic ultrasound imaging sequences. Improved models and methods are
also needed for the attenuation of transient compressional and shear waves in soft tissues, which is signiﬁcant
for shear wave imaging, ultrasound microscopy, quantitative ultrasound, and ultrasound tomography. The main
goal of this proposal is to create valuable new software resources that will enable new solutions of fundamental
problems in medical ultrasound through the completion of three speciﬁc aims. In Aim 1, we propose to create new
transient nonlinear full-wave ultrasound simulations for histotripsy using the discontinuous Galerkin (DG) method.
Unlike ﬁnite difference, ﬁnite element, pseudo-spectral, and k-space methods, the discontinuous Galerkin method
is ideal for full-wave models of shock waves evaluated on high performance computing systems. This is important
because all of the existing nonlinear full-wave modeling tools for medical ultrasound that are based on these other
methods encounter signiﬁcant difﬁculties when attempting to model highly nonlinear pressure ﬁelds for histotripsy.
In Aim 2, we propose to create transient full-wave simulations of shear waves with the discontinuous Galerkin
method, which has similar advantages when applied to simulations of shear waves. We will also address another
limitation of present shear wave simulations by augmenting the proposed shear wave simulations with a fractional
calculus model that describes the attenuation and dispersion of shear waves in soft tissue. In Aim 3, we propose
to create new programs for graphics processing units and compute clusters that further accelerate all of the
existing programs in FOCUS, the `Fast Object-oriented C++ Ultrasound Simulator,' in order to facilitate effective
numerical modeling of ultrafast imaging and other ultrasound imaging sequences. Aim 3 will also integrate a
new numerical technique into FOCUS that models the power law attenuation and dispersion described by several
different time-fractional and space-fractional models developed for medical ultrasound. Overall, we anticipate
that the simulation software produced by the proposed effort has great potential to achieve both immediate and
long-term impact across the entire ﬁeld of medical ultrasound, particularly for applications of histotripsy, shear
wave elasticity imaging, and other therapeutic and diagnostic ultrasound applications.

Public health relevance
Project Narrative Many important research developments in diagnostic and therapeutic ultrasound are enabled by large-scale ultrasound simulations, which are essential tools that are routinely employed in the design, evaluation, and optimization of ultrasound devices and applications. However, the existing software tools for simulating histotripsy, shear wave elasticity imaging, ultrafast imaging, and related methods in medical ultrasound have several funda- mental weaknesses that are presently hindering progress in these emerging areas. To address these deﬁciencies, we propose to develop new high performance computing-based solutions to these and other important problems in therapeutic and diagnostic ultrasound.